Microscopic EB-OCT imaging to predict progression in interstitial lung abnormalities

Project Summary
Progressive pulmonary fibrosis (PPF) is debilitating with poor prognosis. Antifibrotic therapies in PPF slow
progression but do not reverse or stabilize disease. Thus, timing of therapy is key to improving outcomes,
especially if started in presymptomatic stages prior to lung function decline. To prove the efficacy of early therapy,
clinical trials will require prognostic enrichment with biomarkers to accurately identify presymptomatic individuals
at high risk of developing PPF. Interstitial lung abnormalities (ILA) on CT are linked to increased risk of PPF, but
not all ILAs will progress (progression rate ~30-60%) and CT is unable to distinguish ILAs that will progress to
PPF from those that are of no clinical consequence. The main limitation of CT is its resolution, which is insufficient
to detect microscopic features. Surgical lung biopsy (SLB) provides tissue for microscopy, but has high
morbidity/mortality risks. Over the last 10 years, we have developed and validated endobronchial optical
coherence tomography (EB-OCT) as a safe, minimally-invasive imaging modality to assess lung disease, with
microscopic resolution 200x higher than CT in tissue volumes 100x larger than SLB. We have established that
the subpleural space of both lungs can be practically and rapidly (10 sites in <10 min) evaluated in early PPF
using EB-OCT, with 100% sensitivity/specificity for early lung fibrosis as compared to SLB, without adverse
events. We have additionally developed and validated artificial intelligence methods for automated segmentation
and volumetric quantification of microscopic features on EB-OCT with sensitivity/specificity >0.9, allowing for
broad implementation of this technology to define an individual patient’s risk for ILA progression to PPF. With
these major developments in EB-OCT, we finally can safely investigate microscopic disease features in ILA that
may predict progression to PPF. In a preliminary cohort of ILA subjects, we identified high-risk features of early
architectural distortion by EB-OCT that predicted progression of ILA to PPF. Our compelling premise and
preliminary data support our central hypothesis that individuals with ILA who will progress to PPF have high-risk
microscopic features, defined as destructive fibrosis with microscopic honeycombing or traction bronchiolectasis,
that are detectable by EB-OCT. We are uniquely positioned to test this hypothesis due to our expertise in EB-
OCT and access to two large ILA cohorts with annual follow-up (with CT and PFT) to assess long-term outcomes
through our lung nodule CT screening program (smokers with ILA; Cohort 1) and existing ILA cohort (subjects
with ILA and family history of PPF; Cohort 2). In Aim 1, we will determine the accuracy of microscopic features,
as detected by EB-OCT, to predict progression to PPF in two independent ILA cohorts. In Aim 2, we will define
and validate an integrative prediction model for progression of ILA to PPF that combines EB-OCT, CT and
plasma biomarkers associated with PPF disease progression. Cohort 1 will serve as the derivation cohort and
Cohort 2 as a separate, de novo validation cohort. These foundational studies will enable prognostic enrichment
for future clinical trials evaluating early therapy in presymptomatic PPF, with potential to impact disease mortality.

Public health relevance
Project Narrative: Pulmonary fibrosis is a progressive and deadly disease, with a prognosis worse than many aggressive cancers. Early detection and treatment of pulmonary fibrosis is critical to improve patient outcomes and is an important public health priority, but is currently unachievable due to the limitations of standard testing methods. The goal of this proposal is to investigate the use of a low-risk, minimally-invasive, microscopic optical bronchoscopy tool to accurately detect early pulmonary fibrosis at the presymptomatic stages, before significant lung destruction has occurred, which would allow for early treatment and improve patient outcomes.